MI Center for Contextual Factors in Alzheimer's Disease (MCCFAD) Yrs 6-10

ABSTRACT: OVERALL
The Michigan Center for Contextual Factors in Alzheimer’s Disease (MCCFAD) aims to foster and
enhance innovative research in Alzheimer’s disease and related dementias (ADRD) with the
long term goals to 1) advance ADRD-relevant social and behavioral science research in
underserved and underrepresented communities while; 2) diversifying the research workforce
dedicated to healthy aging. This Center builds on a longstanding commitment to advance Diversity, Equity,
Inclusion and Access (DEIA), as well as deep existing infrastructure and research strengths in ADRD and
aging research at the University of Michigan (UM). The Center focuses on the contexts in which ADRD is
experienced. Knowledge concerning the contexts of ADRD is quite limited but has been shown to be critical for
elucidating sociocultural, economic and behavioral contributors to and consequences of health disparities
generally and ADRD disparities specifically. The MCCFAD emphasizes ADRD research in three priority areas:
epidemiology, health economics, and culturally sensitive care. The rationale for these three areas is directly
related to the continued lack of a comprehensive understanding of the contextual complexities inherent in
ADRD disparities, the need to enhance diversity in the professional research workforce addressing the brain
and cognitive health of older adults, as well as dynamic changes in the demographic and multi-cultural
composition of the U.S. population. The MCCFAD promotes diversifying the research workforce dedicated to
healthy aging through collaborations with other NIA-sponsored Centers and programs via connections with R1,
R2 and doctoral/professional universities in Michigan, and by administering inclusive and accessible
educational programs for diverse scholars. The Center’s four Cores are: Leadership and Administrative (LAC),
Research and Education (REC), Analytic (AnC), and Community Liaison and Recruitment (CLRC). Specific
aims are to: (1) Advance ADRD-relevant disparities research in epidemiology, health economics, and
culturally-sensitive care; (2) Recruit and mentor 15 AD-RCMAR Scientists (RS) from the pilot-study investigator
stage through professional publications and independent research applications and funding; (3) Connect with
Middle Eastern North African (MENA) and Latino communities to broaden understanding of intra- and inter-
cultural factors affecting participation in ADRD research. The Center profits from the groundbreaking,
successful work of their extensive network of experienced mentors and experts. These resources, along with
planned structure and activities will ensure that the MCCFAD will continue to have a significant impact in
diversifying the research workforce dedicated to healthy aging while enhancing research to better understand
AD and related forms of dementia across various contexts.

Public health relevance
PROJECT NARRATIVE The Michigan Center for Contextual Factors in Alzheimer's Disease (MCCFAD) focuses on the social and behavioral contexts in which Alzheimer's disease and related dementias (ADRD) are experienced. MCCFAD will lead a coordinated effort to advance diversity, equity, inclusion and accessibility in health research focusing on three priority areas: ADRD epidemiology, health economics, and culturally sensitive care as it seeks to diversify the research in and workforce dedicated to ADRD and advance social and behavioral ADRD research among underserved and underrepresented communities. The Center engages directly with Middle Eastern and North African (MENA) and Latino communities, and links with African Americans through its partnerships with Michigan NIA Centers.